Neural Systems and Behavior

Project Summary / Abstract
Breakthroughs in our understanding of how the brain generates simple and complex behavior and how it
malfunctions in neurological disease and pyschopathology require researchers who have a strong foundation in
neuroscience and a deep understanding of the evolutionary contingencies of human neurobiology and behavior.
Since its inception in 1978, the Neural Systems and Behavior (NS&B) course at the MBL in Woods Hole, MA,
has been the premier course for this kind of interdisciplinary training in multi-level analysis of brain-behavior
relationships. NS&B is an intensive, eight-week summer course that combines lectures, laboratory exercises,
and student-directed research in a unique learning environment. The twenty course students typically come from
diverse disciplines including neuroscience, animal behavior, psychology, mathematics, computer science,
physics, and engineering. They range in their prior training from first year Ph.D. students to faculty members
who are changing fields. The rigorous lectures by the best teachers and researchers in the field provide a solid
foundation for understanding a wide range of subjects, from the basics of molecular genetics and neurogenomics
to electrophysiology and signal processing, and even cognition. Visiting scholars provide further exposure to the
most recent breakthroughs in the study of the neural basis of behavior and cognition. Lunch discussions about
science, ethics, and career development constitute integral parts of the course. The laboratory exercises
(modules) constitute the core of the course and occupy the majority of the students’ time, providing the students
with hands-on experience using state of the art equipment addressing cutting-edge problems. The course is
divided into four two-week cycles with different laboratory modules and sets of faculty, each building upon the
prior experiences of the course. The modules encourage investigations at multiple levels of biological
organization. To maximize learning of research concepts and techniques, the course uses an array of organisms
and preparations to teach techniques and address questions relevant to behavior, the functioning of neural
systems, and neural disease. By the end of each two-week cycle, the students have not only mastered complex
techniques, they also have collected and analyzed data from a research project that they conceived and
designed. The creativity and diversity of these projects are a singular feature of the NS&B course and have never
been replicated in any other educational setting. Students find NS&B to be a life-changing event, not only
because it is intellectually challenging and provides hands on training but also because of the uniquely supportive
environment and networking opportunities that have been hallmarks of the course since its inception. Thus, this
highly successful course provides immersive, hands-on training in state-of the-art research skills essential for
fulfilling objective #1 of the NIMH Strategic Plan: “To define the mechanisms of complex behaviors” by focusing
on neural mechanisms of behavior across the spectrum from single cells to circuits to the whole organism.

Public health relevance
Project Narrative The Neural Systems and Behavior Course (NS&B) provides an exceptional and singular training opportunity that enables the next generation of researchers to tackle the problems central to issues of mental illness. This 8- week course is characterized by a rigorous and innovative curriculum that is focused on discovery research and integrates across diverse levels of biological organization thus leading the alumni and faculty to a better understanding of the human brain and the truly complex causes of mental illness. Since its inception in 1978, NS&B has prepared students to understand how the brain generates behavior by using unique and complementary inquiry-based laboratory exercises to teach experimental techniques, concepts and experimental design at the cutting edge of systems neuroscience.